Hox-Regulated MSCs in Skeletal Development, Growth and Fracture Healing

PROJECT SUMMARY/ABSTRACT
Hox genes are a family of evolutionarily conserved transcription factors that are essential for the proper
development of the axial and appendicular skeleton during embryogenesis. Posterior Hox genes (Hox9-13) are
critical for patterning the skeletal elements of the limb along the proximodistal axis. Specifically, Hox11
paralogous genes pattern the zeugopod, which is comprised of the radius/ulna and the tibia/fibula in the
forelimb and hindlimb, respectively. Recent studies have demonstrated that Hox11 genes are expressed in
skeletal stem/progenitor cell population that self-renews and gives rise to osteoblasts, chondrocytes, and
adipocytes of the zeugopod throughout life. Loss of Hox11 function in skeletal stem progenitor cells impairs
their capacity to differentiate into osteoblasts; subsequently affecting bone remodeling and repair. Further,
Hoxa11eGFP reporter expression demonstrates that Hox11 mutant stem/progenitor cells turn off Hox
expression, leave the stem/progenitor pool and initiate differentiation but fail to differentiate into mature
osteoblasts. These findings are consistent with a model in which Hox11 function is required to establish the
differentiation potential during lineage commitment. Despite well understood genetic contributions to limb
development, maintenance and repair, the mechanisms by which Hox11 regulates skeletal stem cell
differentiation remain unknown. My current work in the Wellik laboratory focuses on identifying Hox11-bound
genomic loci along with RNA-Seq analyses to identify potential downstream target genes that regulate
stem/progenitor cell differentiation. Taking advantage of two newly generated epitope-tagged mouse alleles
(Hoxa11-3XFLAG and Hoxd11-3XFLAG) and using Cleavage Under Targets and Release Using Nuclease
(CUT&RUN) assays, I have identified hundreds of Hox11 binding sites in stem/progenitor cells. However, how
Hox11 transcriptional functions regulate the chromatin state and accessibility of these sites remains unclear.
This proposal seeks to understand the epigenomic landscape regulated by Hox11 during osteochondral
differentiation. In the proposed experiments (Aim 1), I will utilize a novel chromatin profiling method, Multiple
Target Identification by Tagmentation (MulTI-Tag) in embryonic control and Hox11 mutant stem progenitor
cells to define their chromatin status by probing for several histone modifications. Further, I will investigate how
Hox11 function regulates chromatin accessibility during osteochondral differentiation, using ATAC-Seq in
embryonic control and Hox11 mutant stem progenitor cells (Aim 2). Taken together, the proposed experiments
will elucidate the mechanism by which Hox11 function regulates skeletal stem/progenitor cell differentiation in
the development and regeneration of the skeleton.

Public health relevance
PROJECT NARRATIVE Hox11 genes are continuously expressed from embryonic stages through adulthood in a skeletal stem/progenitor population where they serve as critical regulators of osteochondrogenic differentiation. Hox11 mutant stem/progenitor cells initiate differentiation into osteoblasts but fail to mature. This proposal aims to elucidate how Hox11 transcrition factors regulate the chromatin profile and accessibility of skeletal stem/progenitor cells to mediate proper osteochondral differentiation.